SUGAR-CEREAL ON BLOOD GLUCOSE LEVELS FOLLOWING BREAKFAST IN DIABETES

This study will examine glycemic responses (blood sugar level changes) of insulin dependent diabetic children when modest amounts of simple sugars are added to meals. Eight insulin-dependent diabetic children (age 6-18), followed at the Barbara Davis Center and in reasonable diabetic control (last HbA1 below 15%) will be included in the study.